Role of Mitochondrial Health in Acute and Chronic Kidney Disease in Older Adults

ABSTRACT
Over the past decade of this award, we have made substantial progress toward understanding the adverse
impact of chronic kidney disease (CKD) on the health of older adults. Kidney function declines steadily with
age, even in the absence of any clinical risk factors, and reduced kidney function is strongly associated with
myriad cardiovascular and non-cardiovascular morbidities. In addition to glomerular impairments, we have
learned that kidney tubule dysfunction, fibrosis, and injury predict adverse clinical outcomes. These results
suggest that kidney tubular health is pivotal for understanding the development and progression of kidney
disease. In extrarenal conditions affecting older adults such as heart failure or dementia, mitochondrial
dysfunction appears to have a major role in pathogenesis. Like the heart and brain, the kidney tubules rely
upon mitochondrial energy metabolism to support fundamental functions of the organ. In this renewal, we
hypothesize that reduced mitochondrial health is a major cause of kidney disease in older adults, driven by
reduced mitochondrial abundance and oxidative dysfunction that results from accumulated mutations in the
mitochondrial DNA (mtDNA).
Our new preliminary data implicate unexpectedly striking relationships between circulating mtDNA, intrarenal
mitochondrial health, and functional renal outcomes. With emerging therapeutic interest in mitochondria, this
proposal could also lead to novel therapies to prevent and treat CKD. We will leverage innovations in mtDNA
assessment to measure its quantity by copy number and its quality by newly developed next-gen sequencing
methods for mutation burden. Published results already link these measures to overall aging. We will apply
these techniques across three translational Aims: the first two Aims will be conducted in large, well-
characterized cohorts and the third Aim will use human kidney tissue. The first Aim will evaluate whether
mtDNA quantity and quality are associated with risk for acute kidney injury in persons undergoing cardiac
surgery. The second Aim will evaluate associations of the same mtDNA measures with development of CKD
and with progression to kidney failure. The third Aim will utilize a suite of validated techniques to investigate
mitochondrial health in situ using archived kidney tissue from older adults with and without kidney disease: we
will compare measures of mitochondrial biogenesis, mitochondrial quantity, oxidative phosphorylation capacity,
and ultrastructural appearance, and then evaluate their associations with histopathology and clinical status.
These Aims will translate the emerging renal biology of mitochondria into human kidney disease in older
adults. Positive results would: 1) advance mtDNA quantity and quality as potential therapeutic targets for
kidney diseases; 2) develop innovative methods for the assessment of mitochondria in kidney tissue; and 3)
inform selection of patients for future clinical trials of therapies targeted to the mitochondria.

Public health relevance
PROJECT NARRATIVE In older adults, acute and chronic kidney diseases cause enormous burden, but the risk factors for kidney disease are inadequately understood. This application will determine whether reduced quantity and quality of the mitochondria within cells predisposes older adults to the development of acute kidney injury, chronic kidney disease and kidney failure.